Blood and Urine Biomarkers for Predicting Long-Term Adverse Kidney and Cardiovascular Outcomes after Cardiac Surgery

PROJECT SUMMARY
In the United States over 500,000 cardiac surgeries are performed annually. Postoperative acute kidney injury
(AKI) occurs in ~20% of cardiac surgical patients. Several cohort and registry studies have reported that AKI
defined by rise in serum creatinine after cardiac surgery associates with development of chronic kidney
disease and cardiovascular events. However, it is unclear which patients will develop long-term adverse kidney
events, adverse cardiovascular events, or both. In recent years blood and urine AKI biomarkers have been
identified that reflect different aspects of AKI biology and that detect serum creatinine defined AKI earlier than
rise in serum creatinine or detect subclinical AKI that is not revealed by traditional serum creatinine
assessment. Clinical outcomes and biomarker research has focused mainly on detecting cardiac surgery-
associated AKI itself, but not on predicting which patients are at greatest risk for long-term adverse kidney and
cardiovascular outcomes after AKI. The central hypothesis of this proposal is that perioperative blood and urine
AKI biomarkers significantly associate with increased long-term (2 to 5 years) postoperative major adverse
kidney events (MAKE) and major adverse cardiovascular events (MACE). MAKE is defined as the composite
of dialysis, death, renal hospitalization, or ≥ 30 day postoperative eGFR decline >25% from preoperative
baseline. MACE is defined as the composite of death or hospitalizations for heart failure, myocardial infarction,
coronary revascularization, arrhythmia, or stroke. We propose a prospective observational cohort study of 610
patients undergoing cardiac surgery at UT Southwestern Medical Center who will be followed for a minimum of
2 years and up to 5 years following cardiac surgery. Based on preliminary data we will assess plasma NT-pro-
B-type natriuretic peptide, plasma intact fibroblast growth factor 23, serum cystatin C, urine TIMP-2*IGFBP7,
and urine Kidney Injury Molecule-1 AKI biomarkers preoperatively and at 5 postoperative time points. This
proposal will address three specific aims: 1) To determine the association between in-hospital AKI biomarkers
and occurrence of MAKE during long-term follow-up; 2) To determine the association between in-hospital AKI
biomarkers and occurrence of MACE during long-term follow-up; and 3) To develop clinical prediction models
for long-term MAKE and MACE after cardiac surgery. In addition to traditional regression modeling, we will use
machine learning that leverages detailed perioperative data including time-varying intraoperative and intensive
care unit clinical data and blood and urine AKI biomarker data to create high performing prediction models. Our
proposal is significant because knowing what blood and urine AKI biomarkers and clinical parameters
accurately predict long-term major adverse kidney and cardiovascular outcomes after cardiac surgery provides
the foundation for clinical trials that will identify effective short and long-term interventions for patients at
highest risk. Our proposal is innovative because clinical and biomarker data has not been leveraged in this way
to predict long-term MAKE and MACE after cardiac surgery.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because combining blood and urine acute kidney injury biomarkers and clinical data to identify cardiac surgical patients at highest risk for long-term major adverse kidney and cardiovascular outcomes will allow interventional studies to better individualize clinical management to prevent these outcomes. While acute kidney injury after cardiac surgery is associated with increased long-term adverse kidney and cardiovascular outcomes (~25% incidence), it remains unclear which patients with postoperative acute kidney injury are at highest risk. Thus, the proposed research is relevant to the NIH's mission to develop fundamental knowledge that can be applied to enhancing health, lengthening life, and reducing illness and disability.